Defining the contributions of apoptosis to germline syncytium function during oogenesis

Project Summary/Abstract
The health of female gametes (oocytes) decreases exponentially as maternal age increases causing infertility
and miscarriage risks. Infertility affects at least 1 in 4 women of childbearing age in North America and more
worldwide. While medical interventions including in vitro fertilization (IVF) have improved reproductive success,
this is strongly dependent on gamete health. In a human female, oocyte production (oogenesis) begins before
birth where two-thirds of precursor oocytes are normally eliminated by programmed cell death (apoptosis). The
few germline cells that escape apoptosis mature into oocytes. Apoptosis affects oocyte quality through unknown
mechanisms. Studies on the contribution of apoptosis to maternal fertility are limited due to challenges with
performing experiments on humans and even mice, and an underrepresentation of women's health studies in
science. Identifying mechanisms that promote oocyte health will enhance our understanding of factors leading
to infertility and aid fertility health research.
Organ structure is tightly coupled to function, and the ovaries where oocytes are made are no exception.
Throughout animal phylogeny, oogenic germlines are syncytial; they comprise of large, elaborate cells wherein
many nuclei reside in connected compartments. My preliminary work with the oogenic germline of the model
animal Caenorhabditis elegans revealed that disrupting germline structure prevented apoptosis and decreased
fertility. How apoptosis removes certain precursor oocytes at the expense of others is unknown. The goal of this
study is to determine the role of apoptosis in oogenesis and oocyte health as a conserved mechanism like
apoptosis may explain ovary autonomous mechanisms in place to control oocyte quality before ovulation. The
experiments proposed will be performed using the oogenic germline of C. elegans, due to similarities in
proportional time scales of age-related oocyte quality decline and syncytial nature of precursor oocytes within
the ovary. C. elegans has profound experimental advantages including a simple regulation of apoptosis.
The proposed work will be conducted under the mentorship of Dr. Amy Shaub Maddox, with valued collaborators
and a vibrant scientific community. Dr. Maddox has extensive experience with C. elegans, contractility, cell shape
regulation, advanced imaging methods, and theoretical modeling. The lab is well-equipped with all the tools
necessary to define the interplay between apoptosis in germline architecture and function. This project provides
a comprehensive training opportunity for me by teaching me animal physiology and cell biology, microscopy and
data analysis, and mathematical modeling. I will obtain professional development through mentoring
undergraduates, attending networking events, writing, and publishing my work, and presenting at cell biology
conferences like the Triangle Cytoskeleton and the American Society for Cell Biology meetings, with the ultimate
goal of becoming an independent scientist faculty member at a research university in the US.

Public health relevance
PROJECT NARRATIVE Life is sustained through reproduction and renewal; specialized roles which are unique to specific tissues and organ systems. These tissues are composed of complex cells that assemble into complex shapes paramount to their function. This study aims to understand how malfunctions within these complex cells cause fertility defects in the female reproductive system.